Pre-Meeting Planning Activities for Cancer Intervention and Surveillance Modeling Network (CISNET)

Support to the NCI from Scientific Consulting Group for Pre-Meeting Planning Activities for Cancer Intervention and Surveillance Modeling Network (CISNET).